Clinical Research Network in Nonalcoholic Steatohepatitis

PROJECT SUMMARY/ABSTRACT
Metabolic associated steatotic liver disease (MASLD) and metabolic associated steatohepatitis (MASH)
represent a major cause of liver disease morbidity and mortality. The NASH Clinical Research Network (NASH
CRN) has been sponsored by the NIDDK since 2002 and is an international leader in clinical studies in MASH.
The overarching objective of this application is to pursue clinical and translational research in MASH that will
ultimately lead to improvement in the management of patients with MAFLD and MASH. There remains a need
to understand the burden of liver disease and other causes of morbidity and mortality in MASH. New medications
for adults with MASH are currently in clinical trials but no therapies are currently in development for children.
Thus, there is a need for the NASH CRN to continue our leadership in describing the natural history of MASLD
and MASH and to continue our pioneering work in design and implementation of clinical trials for MASH. This
application is for the continuation of the Seattle Clinical Center of the NASH CRN, which has been part of the
NASH CRN since its founding in 2002 and represents a large geographic area with a unique patient population.
Several specific aims are proposed that will advance the objectives of the NASH CRN during the next period of
funding. We will complete enrollment and follow up of MASLD and MASH patients in the adult and pediatric
Database study and VEDS clinical trial. We will focus the latter part of the final 3-year period completing data
analyses and publishing high-impact papers. The PI and Seattle Clinical Center have been leaders in the NASH
CRN since its inception, and we remain fully committed to ensuring the success and impact of this network in
improving liver health and advancing the mission of the NIDDK.

Public health relevance
PROJECT NARRATIVE Metabolic associated steatotic liver disease (MASLD) and metabolic associated steatohepatitis (MASH) are increasingly common and contribute to substantial morbidity and mortality in the USA. The NASH Clinical Research Network (NASH CRN) will continue to conduct clinical and translational research that will advance our knowledge of the pathogenesis, natural history, management and outcomes of MASLD and MASH with a goal to improve the clinical care and treatment of patients with MASH.